Roles of fibrin(ogen) in conformational activation of hemostatic proteinase precursors

Prothrombin and plasminogen, two central hemostatic zymogens, are activated proteolytically by cleavage of an
activation loop. The newly formed N-terminus inserts into a binding pocket and triggers formation of a functional
active site. The activation products thrombin and plasmin respectively form and degrade fibrin, but physiological
regulation prevents uncontrolled clotting and promiscuous plasmin-mediated tissue degradation. The bacterial
virulence factors, staphylocoagulase (SC) and streptokinase (SK), hijack this mechanism by inserting their own
N-termini into the host zymogen pockets, and conformationally activating the catalytic site. The SK-plasminogen
complex proteolytically activates plasminogen to plasmin. Both the SC and SK complexes with the zymogens
and the mature proteases cleave fibrin(ogen) but are impervious to host antithrombin and antiplasmin, and
alternative methods are needed to zcontrol their unwanted activity. Our monoclonal antibodies (mAbs) against
the SC and SK N-termini block complex formation and activity, counteracting infection-related thrombosis and
bacterial spreading in vivo. This illustrates mechanism-based mAb feasibility in an environment of increasing
antibiotic resistance. SC and SK have additional, incompletely defined binding sites for fibrin(ogen) independent
of substrate recognition, that play a role in localization. Our proposal aims to identify unique SC and SK
sequences, and conformational epitopes in their complexes with the zymogens, that promote binding of
fibrin(ogen), both in substrate and anchoring modes. Our group has long-standing expertise with SC and SK-
mediated zymogen activation, and we recently made good progress identifying fibrin(ogen) fragment D binding
to the C-terminal repeats of SC. However, interactions of the SK-plasmin(ogen) complexes with host fibrin(ogen)
are still not well understood. Our short-term goals are to define fibrin(ogen) binding, enhancement of cofactor-
zymogen reactivity by fibrin(ogen), identify binding epitopes, and develop in vivo effective mAbs that will be
added to our existing antibody arsenal. We combine our structure-function and mechanism expertise with that
of experts in mAb development (Dr. Bill Church), and in application of mouse models of SC and SK action (Dr.
Peter Panizzi). Aim 1 will define dual interaction mechanisms of the SC-prothrombin complex with fibrin(ogen),
with the goal of identifying suitable linear and conformational epitopes for blocking fibrin(ogen) binding. Aim 2
will delineate fibrin(ogen)-dependent plasminogen activation mechanisms of S. pyogenes SK variants that to
date are not well defined, with the same goal of identifying fibrin(ogen)-binding epitopes on the SK variants. Aim
3 will test our humanized mAbs targeting the N-termini of SC and SK in vivo, and select tight-binding anti-
fibrin(ogen) binding site mAbs for in vivo studies. Long-term goals for future funding cycles are the development
of mAbs that that cross-react with a wide range of serotypes and allelic variants, and may qualify for pre-clinical
and clinical testing. Cocktails of these mAbs would support the patient's hemostatic system by minimizing
plasmin-mediated bacterial spreading and unwanted prothrombin activation without causing bacterial resistance.

Public health relevance
We will solve poorly defined mechanisms by which bacterial staphylocoagulase and streptokinase hijack the human hemostatic system, with critical involvement of host fibrin(ogen). Human prothrombin and plasminogen form active complexes with these bacterial proteins, and the complexes recognize fibrin(ogen) both as substrates and anchoring points. Knowledge of these mechanisms will allow development of new therapeutic antibodies that may protect patients with a fragile hemostatic system from adverse side effects of infection.